Optimization of delivery of HEX for treatment of primary amebic encephalitis

Project Summary
Brain infections by the pathogenic free-living amoeba Naegleria fowleri are life-threatening
and typically (>95% of the time) result in patient fatality. We have identified a potent
inhibitor, HEX, of the amoeba enzyme enolase (NfENO), that is well-tolerated in mammals
and can extend life of infected rodents. The goal of this proposal is to optimize delivery of
HEX to achieve curative concentrations in the brain. To date, resolution of brain distribution
has been challenging due to the small size and charged nature of HEX. Here, we will
develop mass spectrometry methods required to assess brain distribution of the inhibitor
which will enable optimization of delivery approaches and schedules. Additionally, we will
score the value of partner drugs in the treatment of disease in a rodent model. Together,
these experiments will serve as a key step in progressing HEX toward investigational new
drug status for N. fowleri infections.

Public health relevance
PROJECT NARRATIVE Work proposed here will optimize delivery of a promising metabolic inhibitor of N. fowleri that is toxic to the pathogen and assess the value of the inhibitor, HEX, in combination therapies with other anti-amebics in a rodent model of disease. The described work is a critical step in maturing the compounds into a treatment for the lethal disease caused by the organism. We will use a combination of biochemical and model animal experiments to resolve the best means to deliver HEX to the brain and then score this approach for its impact on infection treatment.